Beyond cell shape: A novel role for the bacterial actin MreB in chemotaxis

Project Summary/Abstract
The cytoskeleton is important for proper physiology in both eukaryotic and bacterial
cells. However, unlike eukaryotic cells, for which much work has been done to
determine the role of the cytoskeleton in cellular physiology, there has been very little
work on this aspect of bacterial cell biology. Disruption of the cytoskeleton often leads to
cell shape changes and cell death. The major actin homolog in bacteria is MreB and it is
thought to be essential for rod shape.
The goal of this work is to remove this black box of microbiology and determine the role
of the cytoskeleton in microbial physiology. A deeper understanding of MreB’s function
and bacterial physiology can guide the development of novel antibacterial therapies, as
well as provide insight into the evolution of the cytoskeleton. Disrupting basic physiology
will make it difficult for infections to take hold in the body, giving the host’s natural
defenses time to clear the infection. This proposal will focus on the role of MreB in cell
shape regulation, growth, and chemotaxis.
To understand how MreB functions we will take a systematic approach MreB using a
combination of genetic, biophysical, and microscopy techniques to building and
analyzing an alanine-scanning mutagenesis library of MreB mutants that have replaced
the native allele. We will analyze the effect of these mutations on multiple aspects of cell
shape and look for suppressor mutations to loss of cell shape. We will screen this library
for the effects on chemotaxis to determine domains of MreB that interact with the
chemotaxis machinery.
All together this research will determine the role of the bacterial cytoskeleton in bacterial
chemotaxis, cell shape, and growth. These insights will provide a starting point for the
development of novel therapeutics that can be used to stop or slow infections, giving the
host immune system time to clear the infection. Additionally, many pathogens use
flagella-based motility to increase their virulence. Learning more about how chemotaxis
works will enable us to develop therapies that can inhibit motility in the host, lessening
infection. To the best of our knowledge, this study will be the first to take a systematic
approach to understanding MreB biology.

Public health relevance
Project Narrative While the bacterial cytoskeleton is biochemically similar to the eukaryotic cytoskeleton, it has not been highly targeted as an antibiotic target nor is it well characterized for its roles in cell physiology. Preliminary results suggest that the bacterial cytoskeleton controls multiple aspects of cell physiology and this proposal aims to understand how the actin homolog MreB regulates rod shape and growth and to characterize the interplay between the cytoskeleton and bacterial physiology.